Alcohol Intervention Treatment Outcome Research Training

Summary/Abstract
The specific aims of our postdoctoral training program are threefold. First, we aim to recruit a diverse group of
early-career behavioral, biomedical, and social scientists, as well as health care professionals who want to
conduct high quality research in the early intervention and treatment of alcohol problems. Second, we strive to
provide fellows with rigorous interdisciplinary training in addiction science and grant writing through a
combination of didactic and practical training and individualized mentorship from leading researchers and
clinical scientists. And third, we ensure fellows reach their own individual scientific career objectives by tailoring
training opportunities to their unique goals and needs. From its inception, distinctive features of our program
include its interdisciplinary nature, focus on training in early intervention and treatment of alcohol misuse along
a continuum with attention to crucial health disparities, and emphasis on highly individualized opportunities to
develop competitive grant applications and by doing so, contribute new knowledge about alcohol-related
dysfunction and treatment. The fellowship emphasizes that intervention should be guided by sophisticated and
fully developed theory that considers biological, social, and cultural influences and contexts. We also stress the
importance of integrating theory, research, and the latest technologies to advance prevention and intervention
strategies across development. Fellows gain expertise in the most rigorous and precise experimental and
clinical trial methods, and learn the most cutting edge and powerful statistical techniques. Across all training
activities, we emphasis responsible conduct of research and the importance of scientific rigor and
reproducibility. Our unwavering mission is to produce the next generation of addiction scholars focused on
innovative research, advanced dissemination and implementation strategies, and public education.

Public health relevance
NARRATIVE This training program is designed to address the significant and costly public health problem of alcohol use disorder by training postdoctoral biomedical, biobehavioral, health care, and other public health scientists to conduct alcohol intervention research. Our program draws on many scientific disciplines, including biological sciences, epidemiology and etiology, prevention, clinical, and public health research, and emphasizes multidisciplinary approaches to achieving innovations in alcohol research. Cutting-edge training of the next generation of alcohol researchers has the potential to accelerate the pace of science in developing effective alcohol treatments.